Novel approaches for the treatment of autoimmune disease

PROJECT SUMMARY/ABSTRACT
The overall goal of this project is to develop a novel therapeutic for the treatment of immune-
mediated thrombotic thrombocytopenic purpura (iTTP). iTTP is an acute, life-threatening disease
that without treatment, leads to a >90% mortality rate. It is caused by deficiency of a disintegrin
and metalloprotease thrombospondin type 1 motif, member 13 (ADAMTS13), which is a protease
that cleaves ultra large aggregates of von Willebrand factor (VWF). Such aggregates of VWF bind
to platelets, resulting in blood clots. Consequently, ADAMTS13 deficiency leads to microthrombus
formation in arterioles and capillaries, and iTTP is characterized by hemolytic anemia,
thrombocytopenia and organ damage, with possible severe cardiac, renal, neurological and
gastrointestinal effects.
For iTTP, ADAMTS13 deficiency is caused by autoantibodies specific for this protease.
Current treatments are therefore directed towards reducing the levels of these antibodies by
plasma exchange and the use of general immunosuppressants (corticosteroids, rituximab). In
addition, a bivalent nanobody (caplacizumab) that inhibits VWF-platelet interactions has recently
been approved to treat iTTP. Despite treatment, however, relapses occur in 30-50% iTTP
patients. Further, the treatments can have adverse effects such as abnormal bleeding
(caplacizumab) and/or increased risk of infection due to general immunosuppression. Rituximab
also has a slow onset of action and is used in combination with plasma exchange. Consequently,
there is a need to develop therapies for iTTP that have rapid effects and high specificity for the
causal agent of disease, namely the autoantibodies.
This application seeks to address the need for new and improved therapies for iTTP by
generating engineered, antibody-based reagents that specifically and rapidly deplete
ADAMTS13-specific antibodies. Importantly, these depleting agents are highly selective and do
not have general immunosuppressive effects. This first-in-class, novel technology has been
named Seldeg technology (for selective degradation).
The Specific aims of the study are:
1. To design and express Seldegs to target ADAMTS13-specific antibodies.
2. To analyze the stability and binding activity of the Seldegs.
The proposed approach could be transformative for the management of iTTP, and also has
relevance to the use of Seldeg-based strategies for multiple other clinical settings where
pathogenic antibodies cause disease.

Public health relevance
PROJECT NARRATIVE Current treatments for immune-mediated thrombotic thrombocytopenic purpura (iTTP), that is caused by autoantibodies specific for a protein called ADAMTS13, are generally immunosuppressive and/or are associated with adverse side effects. In this application we propose to develop a novel treatment that selectively removes the autoreactive antibodies which are involved in the disease process, without affecting the levels of other antibodies that are important for protection against infectious agents such as bacteria and viruses. This approach has the potential to be transformative for the management of iTTP.